Changes in emergency department utilization associated with behavioral health crisis care adoption

PROJECT SUMMARY/ABSTRACT
With 1 in 8 emergency department (ED) visits involving a behavioral health crisis, mental health conditions and
substance use disorders are a leading cause of preventable ED utilization. Yet, the ED is often an inappropriate
and ineffective setting for behavioral health crises. Inadequate access to behavioral health providers leads
individuals to seek care in the ED, even when alternate care settings may be more appropriate to meet their
needs. Behavioral health crisis care (BHCC) is a potential alternative to the challenges of behavioral health
ED utilization. Mental health treatment facilities may adopt a range of BHCC services. The Substance Abuse
and Mental Health Services Administration (SAMHSA) recommends comprehensive BHCC as a best practice,
including the following six services: emergency psychiatric walk-ins, crisis intervention teams, onsite crisis
stabilization, mobile crisis stabilization, suicide prevention, and peer support services. Despite calls to implement
these evidence-based services, my previous work has found that only 6 percent of mental health treatment
facilities currently offer comprehensive BHCC. Importantly, it is unclear how environmental factors such as
community needs and available resources may influence the decision to adopt BHCC services. Additionally, it is
unclear whether access to BHCC actually reduces behavioral health ED utilization. Thus, the objective of this
study is to assess the drivers of BHCC adoption and the potential effectiveness of BHCC at reducing avoidable
ED utilization. Aim 1, assess market factors associated with BHCC adoption, tests the hypotheses that mental
health treatment facilities will be more likely to adopt comprehensive BHCC in 1) more munificent (resource rich)
environments; 2) less dynamic (unstable) environments; and 3) less complex (intricate) environments. This aim
merges a novel dataset on BHCC services with county-level data on environmental factors. Aim 2, assess the
association between BHCC services and behavioral health ED visits, tests the hypothesis that BHCC adoption
will be associated with a decrease in behavioral health ED visits, but not physical health ED visits. This aim will
utilize a propensity score matched panel to examine changes in ED utilization associated with BHCC adoption.
The proposed study is significant because it rigorously measures the impact of a promising, cost-effective model
for behavioral health service delivery. This study is innovative because it extends the evidence-base for BHCC
services through the use of multiple data sources and advanced methodological approaches. Furthermore, this
study is needed to inform policy decisions to expedite BHCC adoption and improve access to underserved
communities. Finally, by examining adoption/implementation and outcomes associated with an alternative model
of care for individuals with chronic conditions and socioeconomic disadvantage, this study effectively targets the
following high priority research area as defined by AHRQ: 1) Increase accessibility and affordability of health
care by examining innovative market approaches to care delivery and financing; and 2) Harness data and
technology to improve health care quality and patient outcomes and to provide a 360-degree view of the patient.

Public health relevance
PROJECT NARRATIVE Increasing access to behavioral health crisis care (BHCC) is relevant to public health because BHCC is a recognized best practice model for improving the care of patients experiencing a crisis due to a mental health or substance use disorder and a more cost-effective approach compared to care delivered in the emergency department. By examining environmental factors associated with adoption of BHCC services, this study can inform decisions to equitably allocate resources and increase access in communities with the greatest need, effectively supporting AHRQ’s research priorities to 1) increase accessibility and affordability of health care by examining innovative market approaches to care delivery and financing; and 2) harness data and technology to improve health care quality and patient outcomes and to provide a 360-degree view of the patient. Further, by measuring the change in emergency department utilization associated with behavioral health crisis care, this study will generate information about whether access to BHCC reduces unwanted and costly emergency department visits, subsequently informing policy decisions about whether to invest in or expand BHCC models.